Mechanism of cytokinesis in fission yeast

1. Project summary: The long-range goal of the project is to understand the mechanism of cytokinesis in enough detail to make useful mathematical models of the process that can predict the results of future experiments. Our experimental organism, the fission yeast Schizosaccharomyces pombe, has been highly advantageous for this work. Over the past 25 years we have provided more quantitative information about cytokinesis in this organism than any other. Nevertheless, essential details are still missing and will be addressed by three lines of research. Our first goal is to determine the molecular organization of the fission yeast contractile ring. We will use quantitative super resolution fluorescence microscopy to make a complete, quantitative inventory of fission yeast cytokinesis proteins and the structures that they form from interphase through the end of mitosis. The second goal is to measure protein turnover in cytokinesis nodes and contractile rings. Our computer simulations of contractile ring constriction revealed that turnover of actin filaments, formins and myosin-II is required to produce tension. The most likely mechanism of exchange is association and dissociation of individual protein molecules over time, but our super resolution fluorescence microscopy data indicate that whole nodes may appear and disappear by a mysterious mechanism during cytokinesis. We will use a new microscopy method to measure the exchange of node and contractile ring proteins with cytoplasmic pools with sufficient spatial resolution to distinguish the exchange of single molecules and whole structures. These projects are powered by innovative methods to count protein molecules and measure their turnover by high speed FPALM super resolution microscopy. Both of these projects will provide essential information to improve mathematical models contractile ring assembly and constriction, which we will pursue with collaborators. The third project is new. We aim to use cryo-EM to determine high resolution structures of actin filament barbed ends associated with two different formins: Cdc12, the cytokinesis formin from fission yeast and mDia1 from mice, which has biochemical properties that differ from Cdc12. Given the evolutionary conservation of many of the participating molecules, I believe that studies of fission yeast will establish the basic molecular pathways controlling cytokinesis in other eukaryotes. 1

Public health relevance
2. Project narrative: We aim to understand the mechanism of cytokinesis in the model organism, fission yeast, using a combination of innovative microscopic methods to make quantitative measurements in live cells and simulations of mathematical models to test and improve our hypotheses. 1